Behavioral Social and Implementation Science Core

PROJECT SUMMARY
THIRD COAST CFAR CORE D: BEHAVIORAL, SOCIAL, AND IMPLEMENTATION SCIENCE CORE
The Third Coast Center for AIDS Research (TC CFAR) Behavioral, Social, and Implementation Science Core
(BSISC) provides a robust infrastructure to enhance development, uptake, and sustainability of effective
interventions that improve the continuums of HIV prevention and care (TC CFAR Overall aim 1). BSISC
resources also support researchers who are addressing non-AIDS comorbidities (Overall aim 2) and innovations
to improve HIV prevention and treatment of persons living with HIV (Overall aim 3). BSISC users and its services
addressing Overall aims 2 and 3 are less numerous than those addressing Overall aim 1, and not less important.
BSISC emphasizes helping all TC CFAR members, and working across all Overall aims, to reach communities
most impacted by the HIV epidemic. This includes young men who have sex with men (MSM) and transgender
women of color. The Core’s aims build on the successes of the prior funding period, including a strong, continuing
focus on implementation science (IS) to move research proven effective into practice at the scale needed.
Resources continuing with enhancement include a BSISC data analyst “embedded” on-site in the Chicago
Department of Public Health (CDPH) and the Illinois Department of Public Health (IDPH) to facilitate rapid access
and analysis of epidemiological data from: 1) partner services; 2) case surveillance; 3) the Medical Monitoring
Project (MMP), a probability sample of HIV-positive persons representative of all receiving care in Chicago; and
4) National HIV Behavioral Surveillance (samples of MSM, high risk heterosexuals, and people who inject drugs).
BSISC also is now adapting or developing person (or patient)-reported outcomes (PROs) for HIV research,
leveraging a strength in research fields other than HIV at our institutions. PROs can enhance scaling up of PrEP
and ART interventions to improve continuums of prevention and care, as well as add new information to research
on non-AIDS comorbidities during ART. Quantitative/qualitative data analyses, IS consultations/trainings,
community engagement assistance, and the BSISC research participant registry (CHAMP) also are applicable
to research on all Overall aims. The BSISC specific aims are: (1) to expand data sources and analytic support
that drive innovative, multidisciplinary collaborations; (2) to provide consultation and training in implementation
science to HIV researchers and their implementation partners that will facilitate movement of evidence-based
HIV interventions into real-world practice; (3) To strengthen community participation in research, as well as
community-engaged research, dialog with the public, and information exchange among researchers.

Public health relevance
A Project Narrative is not required per the RFA.